Interplay between DNA base excision repair and transcriptional regulation

PROJECT SUMMARY
Guanine-rich G-quadruplex (G4) forming sequences are enriched at promoter proximal regions of the genome,
in particular those of cancer and DNA repair-related genes. These regions are hot spots for oxidative lesions
such as 8oxoG, coupling their repair via the base excision repair (BER) pathway to transcriptional regulation.
Unfortunately, the molecular level interactions and mechanistic details of the coupled repair and gene regulation
are not well understood, including the role of DNA structural dynamics, the precise mechanisms of repair and
gene activation, the role of the N-terminal intrinsically disordered region and redox mechanism of BER protein
apurinic/apyrimidinic endonuclease 1 (APE1).
My goal as the leader of my independent research program at Fox Chase over the next five years is to empower
and support a diverse team of young scientists to characterize the molecular-level interactions and coordination
events coupling the repair of oxidative DNA damage and gene enhancement at G4 promoters in response to
oxidative DNA damage. This will involve implementing a multi-disciplinary approach of techniques ranging from
structural biology and single-molecule fluorescence to cell-based assays.
By filling the current gaps in knowledge I will position my research program toward our long-term vision of
developing novel therapeutics that can modulate transcription of key disease-associated genes through
interfering with the key regulatory protein:protein and/or protein:DNA interactions.

Public health relevance
PROJECT NARRATIVE DNA damage arising from oxidative stress promotes multiple human diseases, and the cell’s primary defense against these lesions is the base excision repair (BER) pathway. The overarching goal of this study is to elucidate the molecular mechanisms coupling two key biological tasks in response to oxidative DNA damage at certain G- quadruplex promoter sequences –specifically, BER and the transcriptional activation of genes associated with cancer and other diseases. By elucidating the mechanism of gene activation, the findings of this proposal will provide the details required for rational drug design towards targeting their expression by disrupting the key regulatory protein:DNA interactions.